Animal Core

PROJECT SUMMARY / ABSTRACT (ANIMAL MODELS & PHENOTYPING CORE)
The Animal Models and Phenotyping Core (AMPC) supports animal-based studies across the NORC theme of
“Nutrition, Obesity and Metabolic Health through the Lifespan”. These services focus on two primary areas: 1)
the controlled manipulation of gene expression in rodents, and 2) provide state-of-the-art in vivo metabolic and
behavioral phenotyping. Over past funding cycles, the AMPC has been a key component of the overall mission
of the Pennington/Louisiana NORC, enhancing and facilitating funded research while also stimulating new and
innovative research related to nutrition and obesity. The AMPC is essential for a broad range of research within
the NORC, supporting more than 36 NIDDK and other NIH grants in the past cycle while also interacting closely
with the Administrative Core, Molecular Mechanisms Core, and the Human Phenotyping Core to assure success
in achieving the Specific Aims of each research project. This critical support will be sustained in the current cycle
by: A) continuing to utilize transgenic and gene targeting techniques to generate rodent models that mimic human
metabolic disease states; B) using state of the art equipment and technology to conduct detailed in vivo metabolic
and behavioral phenotyping, and; C) providing consultation related to rodent nutrition and obesity research,
training in the use of experimental services, and pursuing new methods and experimental paradigms that
anticipate the needs of NORC members and Pilot and Feasibility projects. Through these goals, the AMPC will
directly support the use of animal models to better understand human disease states in a translational research
approach while also facilitating cross-talk among scientists focused on nutrition and obesity research.